Therapeutic Potential and Mechanisms of Tau Reduction in Autism Models

PROJECT SUMMARY
The autism spectrum disorders (ASDs) affect 1% of the world’s population. The syndromes in this diverse
family of disorders share three core features: impaired social interactions, communication deficits, and
repetitive behaviors. In the United States, 1 in 68 children are now diagnosed with ASDs, a drastic increase
over the last few decades. Despite the perceived “epidemic” of ASDs, there are few effective treatments. In
roughly 30% of patients, ASD is associated with epilepsy that is often also refractory to available treatments.
Thus, there is an urgent need to develop better treatments for these challenging conditions.
The core symptoms of ASDs are common in Dravet syndrome, an intractable epilepsy with onset in early
childhood. We recently demonstrated that genetic reduction of tau, a microtubule-­associated protein implicated
in neurodegenerative disorders, prevents or markedly reduces epileptic seizures, cognitive deficits, and
premature mortality in a model of Dravet syndrome (Scn1aRX/+ mice). More surprisingly, we found that tau
reduction ameliorated social impairments, communication deficits, and repetitive behaviors in these mice.
Genetic reduction of tau also ameliorated similar communication deficits and repetitive behaviors in a separate
model of ASD (Cntnap2–/– mice). Encouragingly, genetic tau reduction was well tolerated throughout the
lifespan, tau knockdown initiated in adulthood also did not cause obvious adverse effects, and complete
ablation was not necessary, as even partial tau reduction provided substantial benefit. These data led to our
central hypothesis that tau reduction counteracts ASD pathogenesis and may be developed into an
effective treatment for several of these conditions.
However, several key issues must be resolved before this strategy is ready for clinical development. To
determine whether ASD subtypes that do not include epilepsy may benefit from such a treatment approach, we
will examine whether genetic ablation of tau prevents or reduces autism-­like behaviors in a third independent
mouse model of genetically determined ASD that does not develop epilepsy, Shank3B–/– mice. In addition, an
ideal ASD therapy would be effective even if it was administered after symptoms become apparent. To test this
possibility, we will knock down cerebral tau expression in Scn1aRX/+ mice with antisense oligonucleotides after
autism-­like behaviors have become manifest. Finally, we will test hypotheses about the molecular, cellular, and
circuit mechanisms by which tau reduction counteracts the core symptoms of ASD. In the long run, our aim is
to enable tau reduction to be developed into a treatment for multiple ASDs. By determining the consequences
of tau reduction on molecular regulators of development, circuit connectivity, and neuronal properties, we may
also identify additional entry points for therapeutic intervention, to the benefit of patients affected by ASDs or
other devastating diseases associated with tau-­dependent neural network dysfunction.

Public health relevance
PROJECT NARRATIVE Autism spectrum disorders (ASDs) cause substantial disabilities, their diagnosis is rapidly increasing, and they respond only minimally to existing treatment, so new approaches to these challenging disorders are urgently needed. Our preliminary studies suggest that reducing brain levels of the protein tau can prevent or reverse the core behavioral symptoms of ASDs. We propose to assess the therapeutic potential of this strategy in three independent mouse models of autism, and to explore potential mechanisms by which tau reduction may reduce ASD symptoms.